CNS-mediated fever after Adolescent Intermittent Ethanol

Project Summary/Abstract
Alcohol use commonly starts in early adolescence with about 50–70% of 15 year-olds already reporting alcohol
use (World Health Organization, 2018). Human and pre-clinical studies have shown that alcohol increases
vulnerability to both bacterial and viral infections (Szabo, 2015), though adolescent sensitivity to the untoward
effects of alcohol on immune function remain unclear. Importantly, neuroimmune function is severely altered by
binge-like alcohol exposure in rodent models yet the role of CNS-mediated host defense processes has not been
determined. The emergence of a global pandemic driven by widespread novel coronavirus SARS-CoV-2 and its
associated disease state, COVID-19, has revealed unique vulnerabilities for certain demographics. Although the
greatest vulnerability to adverse outcomes of COVID-19 is age, increasing data demonstrate that male patients
with COVID-19 exhibit enhanced disease severity, higher complication rates, and higher mortality However,
there remains great mystery regarding differences in viral infection severity, and the response to vaccine, across
individuals. We propose that a history of alcohol misuse during adolescence may set the stage for adverse
reactions to viral infection and vaccinations. Our prior work has shown that Adolescent Intermittent Ethanol (AIE)
exposure produced long-lasting, sex-specific changes in immune function. AIE exposure substantially impaired
cytokine expression in circulating lymphocytes when challenged in vivo with the bacterial antigen
lipopolysaccharide (LPS), an effect that was robust in males, and completely absent in females. Similar signs of
suppressed cytokine induction were subsequently observed in the hippocampus in response to mild tissue injury,
with other studies reporting impaired fever responses when adolescent alcohol-exposed rats were challenged a
week later with LPS, a TLR4-dependent inflammogen. Although these findings suggest that AIE may produce a
global impairment in inflammatory processes, recent work from our lab suggests that the influence of alcohol
may be pathogen-specific. Specifically, AIE exacerbated the febrile response to polyinosine-polycytidylic acid
(Poly I:C), a synthetic double-stranded (ds)RNA that is used to model viral infections, suggesting that TLR3-
dependent inflammatory processes may be pathologically sensitized by adolescent ethanol exposure. Additional
data suggests that acute ethanol may interfere with the efficacy of anti-pyretic drugs, raising concerns regarding
adolescent binge drinking and altered responding to pharmacotherapeutic treatments for infection later in life.
Therefore, this proposal will test the hypothesis that Adolescent Intermittent Ethanol may represent a latent and
previously unconsidered demographic variable that predicts sex-specific adverse COVID-19 outcomes later in
life. Given the rapid evolution of SARS-CoV-2 and the development of strain variants, the more general viral
model of Poly I:C affords the opportunity to establish general features of host defense that are applicable to both
the current global pandemic, as well as viral outbreaks of the future.

Public health relevance
Project Narrative: Understanding how a history of chronic alcohol exposure during adolescence influences viral host defense mechanisms has direct implications for individuals exposed to SARS-CoV-2 and other viral infections. Importantly, sex differences in vulnerability to COVID-19 adverse outcomes are profound, and require well- established animal models for the development of future therapeutics. This project presents a compelling model system to identify the neuroimmune mechanisms underlying early developmental alcohol exposure effects on virally-mediated host defense mechanisms and potential mechanisms of drug-resistance.